Evaluating the Efficacy of Central Executive Training (CET) For Young Children With ADHD

PROJECT SUMMARY/ABSTRACT
The goal of the current project is to adapt Central Executive Training (CET), an empirically-supported treatment for
school-aged children with ADHD, for use with young children with ADHD. Consistent with NIMH Strategic Objective
#3 and the NIH (1998) Consensus Statement on ADHD, this project will re-develop CET to translate clinical
neurocognitive findings into a novel clinical protocol that affects ADHD behavioral symptoms by targeting central
processes in young children. The final, computerized “CET Junior” protocol will reflect the contributions and
feedback of a diverse group of caregivers, children with ADHD, and recognized experts in child development,
human cognition, ADHD treatment research, RCT intervention design methods, serious game theory and task
design, cognitive training, and the role of executive dysfunction in ADHD. Clinical trial data with older children
suggest considerable promise for improving working memory and ADHD symptoms among youth with ADHD.

Public health relevance
PROJECT NARRATIVE The goal of the current project is to adapt Central Executive Training (CET), an empirically-supported treatment for school-aged children with ADHD, for use with young children with ADHD. CET is a computerized training intervention that targets specific components of the working memory system. CET was developed for use with older children (ages 8-13), and requires significant software revisions and testing to ensure that it becomes developmentally appropriate, feasible, acceptable, and efficacious for use with younger children (ages 4-7). The final “CET Junior” protocol will reflect the contributions and feedback of a diverse group of caregivers, children with ADHD, and recognized experts in child development, human cognition, ADHD treatment research, RCT intervention design methods, serious game theory and task design, cognitive training, and the role of executive dysfunction in ADHD.